Distal effects of botulinum neurotoxins

DESCRIPTION (provided by applicant): The clostridial neurotoxins (CNTs) comprise a family of eight related toxins: tetanus (TeNT) and seven botulinum neurotoxins (BoNT/A-G), which cause the diseases tetanus and botulism, respectively. BoNT/A and BoNT/B are also used clinically to treat a wide range of serious medical conditions, including dystonia and pain; this represents a two billion dollar per year industry. The therapeutic action of the BoNT/A and B has traditionally been thought to involve the local - at the site of injection - inhibition of neurotransmitter release from neurons (by acting as proteases that selectively cleave SNARE proteins); in the case of dystonia, this presumably results in relaxation of skeletal muscles. However, a new hypothesis posits that in addition to having local effects at the site of injection (i.e. at the neuromuscular junction), BoNT/A can also undergo retrograde transport, away from the site of uptake (nerve terminals in the periphery), transcytosis from the axonal to the somatodendritic compartment, release from the latter compartment, and re-uptake into the nerve terminals of upstream, connected neurons in the central nervous system (CNS), where it exerts some of its medicinal effects. Whether any other BoNTs have distal effects is an issue that has not been explored. The goal of this proposal is to directly determine whether any of the BoNTs (A-G) do in fact undergo retrograde transport, transcytosis, release and re-uptake into upstream, connected neurons in a catalytically active form. In Aim 1 we will determine whether toxins that are added to the cis macrochannel of a compartmentalized microfluidic device (which contains only axons), are transported to, and act within, the trans macrochannel of the device (which contains axons, dendrites, and cell bodies). Strikingly, our preliminary data indicate that many of the BoNTs, including BoNT/A and B, do in fact undergo retrograde transport to the trans macrochannel in an active form. This work will include single particle tracking of toxins conjugated to quantum dots (Qdots) to directly visualize, and quantitatively analyze, transport. In Aim 2 we will address the question of whether the toxins undergo transcytosis, release, and re-uptake to act on neurons upstream of the 'primary' neurons that mediated the initial entry step. Release and re-uptake of the toxins would occur via vesicular carriers, and the fusion/recycling of these carriers can be blocked, in principle, using a CNT distinct from the toxi under study. For example, preliminary data indicate that prior cleavage of the SNARE synaptobrevin, in the trans macrochannel, with TeNT, prevents BoNT/A from cleaving its SNARE substrate, SNAP-25, within the trans macrochannel (after BoNT/A was initially taken up in the cis macrochannel). These data directly demonstrate that BoNT/A acts on neurons upstream of the 'primary' neuron that mediated initial entry. By conducting these experiments with all of the CNTs, we will determine which toxins have only local actions, and which toxins have previously undetected distal actions. This work will shed new light regarding the mechanism of action of these agents.

Public health relevance
PUBLIC HEALTH RELEVANCE: The BoNTs are the most deadly toxins known to humankind. Paradoxically, these agents also serve as important drugs in the treatment of a broad range of serious medical conditions in human patients, but the means by which they exert their clinical effects remains unclear. The proposed studies will clarify the mechanism of action of these toxins by definitively determining whether they can move within networks of neurons to have effects distal from the initial site of injection/uptake in patients. These studies will impact the clinical use of the CNTs by determining whether or not they have distal "off target" effects following local administration. Thus, the proposed work uncovers novel aspects of neuronal cell biology and also has important ramifications regarding patient safety. __SpecificAimsTextDelimiter__ Specific Aims: It has recently been hypothesized that many of the clinical effects of botulinum neurotoxin A (BoNT/A; "BOTOX(R)") cannot be explained by a local action at the site of injection in the periphery (i.e. at the neuromuscular junction (NMJ)), and it was proposed that the toxin somehow makes its way into the central nervous system (CNS) to exert many of its medicinal effects1, 2. However, this model has not gain widespread acceptance due to a lack of direct experiments that address the movement and site of action of any of the seven BoNTs (types A-G). In order to directly test this new model for the action of BoNT/A, and to extend these experiments to the other six BoNTs (all of which might eventually be used in human patients), we have devised a simple reconstituted system based on quantum dots (Qdots) and compartmentalized microfluidic devices to monitor putative retrograde transport of the toxins and to assay for 'distal effects' on neurons upstream from the neurons that mediate the initial uptake step. We propose two Specific Aims: Aim 1. Reconstitution and visualization of retrograde transport of the BoNTs: do these toxins undergo retrograde transport? BoNTs are used to treat an increasing range of human medical conditions, but their mechanism of action is not fully understood. It was initially proposed that BoNT/A and BoNT/B (MYOBLOC(R)) exerted their medicinal effects by blocking transmitter release at the site of injection (i.e. at the NMJ in the periphery), but recent - albeit indirect - evidence suggests that many of the clinical effects of BoNT/A result from distal actions in the CNS1, 2. For example, ipsilateral injection - in a mouse model - resulted in the diminution of pain on the contra-lateral side3, and central effects in motor cortex were observed after injection of the toxin into the hand and wrist of human patients1, 2, 4. A local, peripheral action of the toxins cannot explain these effects. However, the idea that these toxins gain access to, and act upon, central neurons has not gained general acceptance among basic researchers owing to a lack of experiments that directly test this hypothesis. To address the disparity between the views of clinicians and basic researchers regarding the site of action of these agents, we have carried out preliminary experiments using Qdots and microfluidic devices. We directly observed that after being taken up by neurons, BoNT/A, as well as a number of other serotypes, do in fact undergo retrograde transport (from the cis to the trans macrochannel of a microfluidic device), and that transport requires intact axons and microtubules. Moreover, some degree of substrate cleavage was observed in the trans macrochannel, suggestive of distal effects (this point is addressed directly in Aim 2). Putative retrograde transport of all seven BoNTs will be quantitatively analyzed in this Aim; TeNT will serve as a control. Aim 2. Do the BoNTs undergo transcytosis, release, re-uptake and action upon upstream, connected neurons? The experiments in Aim 1 will reveal whether the toxins undergo microtubule-dependent retrograde transport from the cis to the trans macrochannel, and whether some degree of cleavage within the trans macrochannel occurs. However, putative SNARE cleavage in the trans channel could be due to diffusion of the free toxin light chain (LC) in the axoplasm of the cell that initially took up the toxin; in this case SNARE cleavage would be restricted to the neurons that mediated the initial uptake step, and extensive 'distal' effects in the trans macrochannel would not be observed (as in the case of BoNT/B; see also Fig. 4 where axons from the cis channel do not branch within the trans channel, and thus cannot provide a means to distribute the toxin within the trans channel). Alternatively, the holotoxin (composed of a LC and a heavy chain (HC)), within a vesicular carrier, might undergo transcytosis, release, and re-uptake into upstream neurons in the trans macrochannel. In this case, after re-uptake of the holotoxin (via the recycling SV pathway, resulting in entry via vesicles that acidify), the LC would be translocated (via the HC) into the cytosol of the 'second' neuron in the chain, where it would cleave SNAREs at distal sites (i.e. in the case of BoNT/A). If this occurs, we predict that we will be able to block release/re-uptake of the holotoxin in the trans macrochannel using clostridial neurotoxins (CNTs; i.e. BoNTs and the closely related tetanus neurotoxin (TeNT)) within this channel, by either inhibiting exocytosis of the holotoxin from the neuron that initially took it up, or by blocking the endocytosis of the holotoxin into upstream connected neurons (by blocking vesicle recycling). Indeed, we found that prior cleavage of a SNARE (synaptobrevin) with TeNT in the trans macrochannel completely protects cleavage of another SNARE (SNAP- 25) by BoNT/A (that was initially taken up the cis channel) within the trans macrochannel. This experiment clearly demonstrates that BoNT/A cleaves SNAREs in neurons other than the primary neuron that initially took up the toxin (via axons in the cis macrochannel). Thus, these experiments provide the first direct demonstration that BoNT/A undergoes retrograde transport, transcytosis, release, re-uptake, and action on upstream connected neurons. This analysis will be applied to all of the CNTs and will reveal which toxins are able to move from one neuron to another. This Aim will significantly advance our view of the mechanism of action of medicinal BoNTs by providing a cellular mechanism for their proposed effects in the CNS. These experiments will be confirmed, in vivo, using a mouse model system as described5.